MMP9 Modulation of Uterine Contraction and Birth Timing

PROJECT SUMMARY
Matrix Metalloproteinases 2 and Metalloproteinase 9 (MMP2/9) play active roles in a variety of cellular
responses, including the regulation of uterine contraction. The underlying molecular mechanisms driving these
effects are currently unknown. The overall objective of the parent proposal is to understand the mechanisms by
which MMP9 promotes uterine contraction and to determine if specific inhibition of MMP9 promotes uterine
quiescence. The central hypothesis is that elevation of MMP9 to levels seen in preterm patients is sufficient to
increase the contractile response in human uterine tissue and drive preterm parturition. The parent project
includes experiments will be performed to determine if MMP9 inhibition can delay parturition in preterm mouse
models. This supplemental project will enhance the parent proposal by identifying genes and proteins whose
uterine expression is altered when MMP activity is systemically blocked. These data are expected to be
significant because these they will identify potential mechanistic links to explain how MMP2/9 modulate uterine
contractions. These data will provide a foundation for future experiments to determine if MMP2/9 substrates
can serve as druggable targets to promote uterine quiescence and reduce the number preterm births.

Public health relevance
PROJECT NARRATIVE The proposed project is relevant to public health because complications associated with preterm birth are the leading cause of infant mortality in the United States. This project is relevant to the NICHD mission because it will provide the foundation to determine if MMP2/9 substrates can serve as druggable targets to promote uterine quiescence and reduce the number preterm births.